Engineered “muco-trapping” antibodies for inhaled therapy of parainfluenza and human metapneumovirus infections

Human parainfluenza virus (PIV) and metapneumovirus (MPV) are common causes of lower respiratory
tract infections in infants and young children, and major causes of respiratory illness in immune compromised
adults and the elderly. Unfortunately, there are no therapy or vaccine for either viruses, and only supportive
medical care is available. Interestingly, PIV and MPV share many pathological and clinical manifestations as
Respiratory Syncytial Virus (RSV). Indeed, neither PIV nor MPV are known to cause viremia in the blood of
infected patients, indicating both infections are strictly localized in the airways similar to RSV that shed progeny
viruses exclusively from the apical surface of infected cells. Such unique pathophysiology implies progeny
viruses must traverse airway mucus (AM) before spreading to neighboring cells. This in turn motivated us to
develop a pathogen-specific antiviral that could physically limit the spread of the infections within the airways.
We recently discovered a novel Ab effector function in mucus – trapping individual pathogens in mucus
based on carefully-tuned affinity between IgG-Fc and mucins – and developed a platform for enhancing mAb
function at mucosal surfaces. We hypothesize that “muco-trapping” mAb delivered to the airways can directly
intervene with the viral life cycle by intercepting and trapping shed progeny viruses in AM, rapidly eliminate
trapped viruses from the airways by natural mucociliary clearance, and enable effective therapy in vivo. In
support of this strategy, we engineered mAbs that potently trap RSV in AM, and showed that nebulized
delivery of “muco-trapping” mAb to RSV-infected neonatal lambs beginning on Day 3 post infection effectively
reduced the infectious viral load in lung tissues to non-detectible levels within 3 days, with viral RNA in
bronchial tissues reduced by 11-fold compared to vehicle control. These results motivated us to explore
whether a similar approach may be effective in treating PIV and MPV infections. In support of this application,
we have engineered antibodies with picomolar affinity to diverse strains of both viruses, and demonstrated that
we could effectively trap viruses in human AM and limit spread of infection in vitro in well-differentiated human
airway epithelium (WD-HAE) grown at the air-liquid interface.
In this proposal, we will continue our work with affinity maturation using mammalian and yeast display
to produce high affinity mAb that broadly bind and neutralize diverse strains of PIV and MPV (Aim 1). We will
validate whether these mAbs can trap PIV and MPV in fresh undiluted human AM, and whether they can inhibit
the spread of pre-established PIV and MPV infections in WD-HAE cultures (Aim 2). We will then advance the
lead mAb for both viruses for evaluation in a hamster nasal infection model (Aim 3). By enabling enhanced
mAb function in mucus secretions, we expect we will help pave the way for improved, molecularly-targeted
therapies and prophylaxis against a broad spectrum of pathogens across all major mucosal surfaces, providing
a powerful option addressing the current gap in pharmacological interventions for respiratory infections.

Public health relevance
Narrative There are no effective vaccines or treatments for human parainfluenza virus (PIV) or metapneumovirus (MPV) infections; both are common causes of viral lower respiratory tract infections in children, immunocompromised adults and the elderly in the U.S., and are important causes of asthma exacerbations, bronchiolitis, and pneumonia. Here, we propose to engineer antibodies that can neutralize diverse strains of both viruses, trap them in mucus, and block their spread within the lung airways where both infections proliferate. If successful in validating their efficacy in vitro and in vivo, our work may provide a framework for developing novel treatments for other respiratory infections.